PHASE I TRIAL OF DENSPM IN PATIENTS WITH REFRACTORY SOLID TUMORS

The purpose of this study is to determine the maximum tolerated dose of DENSPM administered intravenously three times daily for six days; to determine the qualitative and quantitative toxicity of DENSPM administered intravenously; and to investigate the clinical pharmacokinetics of DENSPM administered intravenously.